Targeting Lung Cancer Vulnerabilities

SUMMARY
Summary of Funded Parent Award and Project. The overall goal of the parent project, 5P50CA070907-23
(The University of Texas SPORE in Lung Cancer, “Targeting Lung Cancer Vulnerabilities”) is to identify liabilities
in human lung cancer, understand the mechanistic basis of these vulnerabilities and develop therapeutic
strategies that can be deployed in patients. Dr. DeBerardinis leads Project 1: “Targeting Metabolic Vulnerabilities
in Lung Cancer.” The central hypothesis of this Project is that metabolic phenotypes in human non-small cell
lung cancer (NSCLC) can provide a source of new therapeutic targets and biomarkers that predict
therapeutic sensitivities and clinical outcomes. The Project uses a state-of-the-art approach to assess
metabolism of human lung tumors using stable isotope tracers. In this approach, patients with solitary pulmonary
nodules are recruited to a clinical protocol (NCT01668082) and intravenously infused with 13C-glucose during
surgical resection of the tumor and adjacent lung. Metabolites extracted from tissue samples procured by the
surgeon are then assessed by mass spectrometry to compare 13C labeling between tumor and adjacent,
nonmalignant lung. We have used this approach to assess the causes of metabolic heterogeneity among tumors,
identify metabolic fuels consumed by human tumors in vivo and correlate the metabolic properties of tumors with
clinical markers including FDG-PET signal and outcomes1-3.

Public health relevance
Project 1 Project Narrative Lung cancer is the leading cause of cancer-related deaths in the U.S. and worldwide, and with dismal 5-year survival rates, improved therapies are sorely needed. The goal of SPORE Project #1 “Targeting Metabolic Vulnerabilities in Lung Cancer” is to identify previously unknown acquired vulnerabilities related to tumor cell metabolism in lung cancer and in preclinical models test the effect of targeting these vulnerabilities alone and with clinically available therapies. We use innovative techniques to assess metabolic activity in lung tumors (including tumor cells and the tumor microenvironment) in patients, human xenografts in mice, genetically engineered mouse models (GEMMs) and syngeneic mouse models of lung cancer. This proposal will identify specific metabolic activities that predict disease progression in humans and will thoroughly study the effect of therapeutically inhibiting one such activity, lactate transport, on tumor growth and metastasis in preclinical models in mice. In addition, this project will provide some of the first data on how lung cancer metabolism affects its tumor microenvironment (and vice versa) particularly related to anti-tumor immune responses which will be of value to all of the other SPORE Projects. In the first two years we study lung cancer metabolism in patients. In subsequent years of this Project we will explore clinically translating these findings through early stage therapeutic patient trials.